Core B: Administrative Core

Project Summary
This Program brings together a multidisciplinary team from Baylor College of Medicine, MD Anderson Cancer
Center, Johns Hopkins Bloomberg School of Public Health, Texas A&M University, and Rice University to
examine factors influencing the progression of clonal hematopoiesis to hematologic malignancy in mice and
humans. To facilitate this bold undertaking, Core B (the Administrative Core) will coordinate the activities of the
Program. This Core will (1) facilitate communication within and outside the Program by organizing monthly
scientific meetings including all Program participants and quarterly meetings of Program leadership. The Core
will facilitate an annual meeting including all participants and internal and external advisory board members to
discuss progress and generate feedback. In addition, the Core will ensure that work is communicated to the
scientific community in a timely fashion through presentations, publications, and data release. (2) The Core will
be responsible for sound fiscal management including budgeting and distribution of funds. (3) The Core will
coordinate ongoing evaluation of the Program through internal and external advisory boards and will use the
advisory feedback to adjust the Program plans as needed. (4) The Core will be responsible for ensuring
compliance with ethical considerations with regard to animal and IRB protocol approvals and good laboratory
practices. The Core will ensure that all participating investigators have appropriate and current ethics training.
The Core will also oversee research rigor by ensuring training of all Program personnel and rigorous review.
This Core will also be responsible for statistical evaluation of plans in the Projects. Overall, Core B will facilitate
the highest level of productivity throughout the Program, allowing each Project and Core to work together to
achieve our overall goal of understanding how modifiable stressors cause expansion and malignant
transformation in patients with clonal hematopoiesis.

Public health relevance
Project Narrative The Administrative Core (Core B) will coordinate smooth running of the overall program, ensuring communication, fiscal responsibility, and evaluation and ethical standards among participants of all five institutions.